Collaborative care teams for hospitalized patients with opioid use disorders: Translating evidence into practice

Project Summary/Abstract
The underuse of effective behavioral health treatments during the hospital stay is a translational science problem
that has important consequences. Behavioral health comorbidities are common among hospitalized patients,
and are associated with longer lengths of stay, higher costs and worse outcomes. Treatment for opioid use
disorder (OUD) is an exemplar of this problem. Patients with OUD are frequently hospitalized, and while
treatment is effective, it is dramatically underutilized, leaving patients at high-risk of continued misuse, future
overdose, and readmission. There are multiple reasons for this translational inefficiency. While inpatient
physicians frequently treat acute overdose and withdrawal, they have limited knowledge and training in
behavioral health. Given pressures to minimize length of stay, the team usually prioritizes addressing the acute
reason for admission. Moreover, few hospitals have the organizational infrastructure needed to treat behavioral
health conditions effectively, such as dedicated teams, evidence-based protocols, or the ability to coordinate
transitions of care such that patients can be linked to outpatient and community resources.
Interdisciplinary, collaborative care teams (CCT) are a new approach to address translational roadblocks in OUD
treatment delivery and have the potential to make a significant contribution to narrowing the treatment gap. Our
prior work demonstrated the effectiveness of CCT when used with primary care patients with addiction, but CCT
have never been tested as a translational approach in the inpatient setting. If effective, CCT could completely
change the paradigm for addressing behavioral health disorders in the inpatient setting. We propose a mixed-
methods, multi-site, randomized pragmatic trial in three sites to evaluate whether CCT increase translational
efficiency, among hospitalized patients with OUD. We will randomize 414 patients total from Cedars Sinai
Medical Center in Los Angeles, the University of New Mexico Hospital, and Baystate Health in Massachusetts
to receive either CCT or usual care. Our primary outcomes are inpatient MAT initiation and linkage with post-
discharge OUD treatment; secondary outcomes include days spent alive and in the community, treatment
engagement, and opioid misuse. To inform future dissemination efforts, we also evaluate contextual factors
affecting implementation, the sustainability of the CCT post-implementation, and costs. By blending components
of clinical effectiveness and implementation research, leveraging the CTSA consortium including the Treatment
Innovation Network and Recruitment Innovation Center, this innovative approach to translational research can
generate more rapid translational gains, more effective downstream implementation, and will enhance the
efficiency and science of translational research. The CCT offers expertise that most hospital-based physicians
lack, creates an organized system of care, and addresses barriers to follow-up care. Knowledge from this study
could transform the hospital experience into an opportunity to engage patients with OUD in MAT, resulting in
reduced suffering, immediate and long-term gains in patient health, and decreased healthcare costs.

Public health relevance
Project Narrative Despite frequent hospitalizations, patients with opioid use disorders (OUD) are rarely started on effective pharmacotherapy and linked with aftercare, leaving them at high-risk of continued misuse, future overdose, and readmission. We will test the effectiveness of an interdisciplinary, collaborative care, addiction consult team, on increasing the initiation of opioid pharmacotherapy in the hospital and linking patients with post-discharge care. Knowledge from this study could transform the inpatient hospital experience into an opportunity to engage patients with OUD in effective care, resulting in immediate and lasting gains in health and functioning.